Computational Model of Neurocognitive Impairment in Multiple Sclerosis

Project Summary/Abstract.
The goal of this project is to provide a long overdue psychometrically valid and biologically informed update of
cognitive status in relapsing remitting and progressive multiple sclerosis (MS). The existing framework used to
characterize cognition in MS assumes slowing of cognitive processing speed (COG SPD) is the primary
cognitive disability and slowing causes impairments in other cognitive domains (e.g., memory). This framework
has never been prospectively tested, does not incorporate the past two decades of advances in disease
management, including treatment discoveries that slow disease progression alongside improved diagnostic
sensitivity leading to ascertainment of milder cases and has not been updated in over 30 years. The speed-
centric framework depends on invalid polyfactorial psychometric COG SPD assessment tools. There is no way
to know if low scores indicate impaired COG SPD or impairments in other cognitive domains. Cognitive
psychology and computational modeling offer strong frameworks to investigate a psychometrically valid,
theoretically derived, and empirically testable model of the time-course of cognitive processing in MS.
Specifically, the diffusion model (DM) is an empirically validated mathematical method that extracts 'less
contaminated' dissociable components of cognitive processing. Components include rate of information
accumulation (COG SPD), criteria necessary to make a cognitive decision, and stimulus encoding/motor
response execution. Our preliminary psychometrically valid computational modeling research strongly supports
a revised cognitive profile in MS that is likely a result of the clinical advances in disease treatment and
diagnosis. In aim 1, we translate and integrate cognitive psychology and computational modelling with
confirmatory factor analysis to reappraise and prospectively test the longstanding speed-centric model of MS
cognition and determine whether there are domain general vs. domain specific changes in DM cognitive
processes across MS phenotypes. We test the specific hypothesis that MS cognitive impairment is primarily
due to changes in stimulus encoding/motor response execution with larger differences in the progressive
compared to relapsing remitting disease course. We also test the hypothesis that COG SPD is impacted in
more advanced progressive disease where neurodegeneration is more prominent. In aim 2, we investigate the
predictive value of DM components of cognitive processing and use structural equation modeling to evaluate
relationships between DM cognitive processes and brain pathology (T2 lesion and normalized brain volumes)
along with patient reported outcomes (PRO: psychological/psychiatric and cognitive symptoms) and
performance in other cognitive domains (derived from extensive neuropsychological battery). This will lead to a
comprehensive scientific understanding of the dynamic interplay across what cognitive domains are impaired
in present-day MS, at what stages of disease and pathology, and moderating effects of PROs that will allow us
to closely monitor and develop treatments that specifically target those domains and/or moderating variables.

Public health relevance
Project Narrative. The existing framework used to characterize cognitive impairment in multiple sclerosis has never been prospectively evaluated, does not consider the latest clinical advances and depends on non-specific polyfactorial psychometric tools. In this project, we propose an updated biologically informed and psychometrically valid model of cognition that we will test using sophisticated statistical tools including computational modeling, structural MRI, confirmatory factor analysis and structural equation modeling. This project will provide an updated scientific framework to understand the basic mechanisms of cognitive dysfunction in multiple sclerosis, thus leading to psychometrically valid endpoints and forging a path to new treatment discoveries that improve quality of life.